Non-Invasive MRI Markers to Elicit the Role of Vascular Disease in CADASIL Compared to Normal Aging

Project Summary/Abstract:
The project addresses vascular contributions to cognitive impairment and dementia (VCID) using a design that
enrolls persons with the autosomal dominant gene for Cerebral Autosomal Dominant Arteriopathy with
Subcortical Infarcts and Leukoencephalopathy (CADASIL). Exploration of VCID by focusing on the rare heritable
monogenic disorder, CADASIL, will advance knowledge of the full spectrum of this vascular dementia from
asymptomatic gene carriers through dementia and will facilitate studies evaluating vascular contributions in
different neurodegenerative processes including Alzheimer’s disease (AD) and related dementias (ADRD).
CADASIL is caused by a mutation in the gene Notch3, which encodes a receptor protein expressed in vascular
smooth muscle cells and pericytes. When mutated, expression of the gene leads to generalized degeneration of
vascular smooth muscle cells affecting small and medium sized arteries. To provide insights into the impact of
small vessel disease (SVD) in CADASIL (and AD, ADRD, and VCID more generally) on parenchymal damage
and cognitive decline, non-invasive Magnetic Resonance Imaging (MRI) provides quantification of brain
structure, function, and some measures of vascular health; however, current clinically available MRI techniques
lack sensitivity and specificity to address key vascular hypotheses as many measures only indirectly study
cerebrovascular disease, primarily focusing on the damage already caused by SVD, not the vessels themselves.
Our group is uniquely positioned to address these key gaps in our knowledge base, both due to our MRI
technology and as a member of the first CADASIL consortium study in North America. We propose an ensemble
of novel MRI techniques optimized to provide vascular specific measures in a non-invasive imaging protocol. By
characterizing in vivo measures of vascular stiffening at the macrovascular and microvascular levels in CADASIL,
we will provide insights into the degree and mechanisms of VCID and establish baseline data to compare the
longitudinal time course of CADASIL with normal age-related cerebrovascular changes, including SVD. We
previously found that our MRI stiffness measures can detect vascular changes in amyloid positive AD participants
even prior to demonstrating cognitive dysfunction. Our pilot data in CADASIL suggests pronounced vascular
disease involving all levels of the cerebrovascular system. In close collaboration with three additional CADASIL
consortium sites, a multidisciplinary team at the University of Wisconsin will first utilize newly developed, state-
of-the art, quantitative MRI vascular imaging methods to understand the distribution and severity of vascular
changes in CADASIL (Aim 1). We will then study the influence of altered intracranial vasculature on CADASIL
neurodegeneration and cognition (Aim 2), and finally, we will study the degree of vascular involvement in
CADASIL in comparison to cognitively unimpaired, normal aging participants (Aim 3). Upon completion we will
be uniquely positioned to incorporate these techniques into large cohort studies investigating SVD, VCID, and
extending into other ADRD vascular mechanisms as well as evaluate risk and protective factors.

Public health relevance
Project Narrative: This research aims to establish novel markers of cerebrovascular disease (CVD) for the sensitive and specific evaluation of vascular contributions to cognitive impairment and dementia (VCID) by studying non-invasive vascular specific MRI markers in CADASIL, the most common heritable cause of vascular dementia. Through this, we aim to understand the influence of both macrovascular and microvascular disease on CADASIL neurodegeneration and cognition. The degree of vascular disease involvement at various stages (normal cognition, mild cognitive impairment, and dementia) of CADASIL (Notch3 mutation carriers) will then be compared with cognitively unimpaired normal aging participants without known neurodegenerative diseases including Notch3 mutations, thereby facilitating examination of other types of VCID and mixed dementias.